Pathology Core

PROJECT SUMMARY
The purpose of this shared resource is to provide human tissues, biological fluids, and expert pathologic
interpretation for project investigators. The Pathology Core will work with an existing resource, the GI SPORE
Tissue Bank, which is under the same director (Dr. R. Anders) as this proposed Pathology Core, to establish a
collection of properly banked liver tissue and biological fluids. The tissue samples will range from formalin-
fixed paraffin-embedded and frozen tissues available from liver transplantation specimens which will be linked
to clinical data. This Pathology Core will collect high quality snap frozen and formalin fixed samples from liver
transplant patients. The biospecimens will be harvested and banked in accordance with the National Cancer
Institute’s Best Practice Guidelines for Biorepositories. Distribution of these specimens to project investigators
will be coordinated by the Pathology Core director. This CORE will procure specimens under the supervision of
a pathologist with expertise in hepatopathology and in close collaboration with surgeons, transplant
hepatologists and basic research investigators to maximize translational impact of the projects. This proposed
CORE will leverage existing database framework, specimen distribution and prioritization systems that
originated from existing SPORES. Specifically, we will have clinical histories linked to pathologic data in a
password protected database. A mechanism will be in place for prioritization of distribution of requested
resources to investigators within and external to the Johns Hopkins Medical System.

Public health relevance
In the United States, alcoholic liver disease is the second most common indication for liver transplant. This core resource will thus support the projects of this application related to the diagnosis and treatment of liver disease with high quality evaluation and collection of tissues.